FOLLOW UP STUDY OF MULTIMODAL TREATMENT STUDY OF CHILDREN W/ ADHD

The purpose of this study is to continue to follow and assess the original MTA study participant as well as recruit a grade and gender matched control sample form the same schools as the MTA subjects. Both groups will receive a similar battery, approximately yearly, over the next four years.